DISSEMINATION 2007-2008

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. NRBSC dissemination efforts include Publications and outreach, including journal and book articles, articles in the annual PSC science book, online courses and webcasts of workshops, and 3-D and stereo animations for meetings, seminars, museums, science centers, and K-12 audiences, and software distribution of complex research codes including improving and disseminating community codes to scientific users